Identification of fish pathogens in California

PROJECT SUMMARY/ABSTRACT
The California Animal Health and Food Safety (CAHFS) system, within the University of
California, Davis School of Veterinary Medicine (SVM), is comprised of four laboratories
dedicated to veterinary diagnostics. As an accredited member of the American Association of
Veterinary Laboratory Diagnosticians (AAVLD), CAHFS adheres to rigorous standards and
maintains strict oversight of all standard operating procedures to ensure results are accurate,
repeatable, and consistent. Microbial testing of clinical samples and food matrices is an integral
part of our core mission. CAHFS functions as the state veterinary diagnostic laboratory serving
the food animal industries for routine clinical diagnostics, for regulatory testing and for food
pathogen monitoring. The demand for diagnostic testing for fish species is increasing and
CAHFS is currently building capacity to enhance the fish and aquaculture testing that can be
offered. Among the major areas of interest are correct identification of bacterial organisms
associated with fish disease, as well as antimicrobial susceptibility testing (AST), or detection of
antimicrobial resistance genes as an alternative to in vitro AST, given the challenges with growth
of most fish pathogens under routine culture conditions and the general lack of clinical
breakpoints and laboratory standards for performing AST in fish. CAHFS has not previously
received capacity building funding and is applying for this opportunity to grow our fish diagnostic
program, including bacterial WGS sequencing capability, the development of a custom fish
pathogen MALDI-TOF library to enhance rapid and accurate identification of fish bacterial
organisms from clinical samples, and genomic AMR surveillance. Furthermore, with the capacity
to perform WGS on microbial pathogens, CAHFS would be better able to contribute to animal
and food pathogen sequencing efforts and participate in Vet-LIRN programs. The CAHFS
system is uniquely qualified to assist with the Veterinary Laboratory Investigation Response
Network (Vet-LIRN) mission and is at the forefront of monitoring antimicrobial resistance among
livestock animals in coordination with the California Department of Food and Agriculture’s
Antimicrobial Use and Stewardship program.

Public health relevance
NARRATIVE The California Animal Health and Food Safety (CAHFS) system functions as the state veterinary diagnostic laboratory providing testing for mammalian livestock species for decades and is now building capacity for diagnostic testing for fish species. Whole genome sequencing capabilities to correctly identify bacterial pathogens associated with diseases of fish and detect antimicrobial resistance genes for surveillance and clinical purposes will advance our ability to provide service to the fish and aquaculture industries. CAHFS is positioned to conduct this work given expertise of faculty and staff as well as the having the equipment required to perform the work.